Proteomics and Lipidomics Core

Proteomics and Lipidomics Core (C. Vary, Core Director)
The Proteomics and Lipidomics Core is led by Calvin Vary PhD and provides high quality research design
support, sample preparation, mass spectrometry analysis, data collection, and data analysis for a variety of
tissues and cells. As a component of the COBRE in Mesenchymal and Neural Regulation of Metabolic
Networks since 2017, our services have focused on protein and lipid profiling in mouse and human tissues.
Our goals remain to: 1) provide new approaches that expand previous protein identification capabilities, 2)
provide unbiased analytic workflows for proteomics and lipidomics studies that include 3) further developing
targeted protein (e.g., MRMHR, SRM) and lipid quantitation (MSMSALL, MPIS) workflows, and 4) provide
improved statistical and informatics approaches for data interpretation and identification of mechanisms.
In Phase I of this COBRE, the Proteomics and Lipidomics Core consistently supported basic, translational, and
clinical research projects and grant applications. These have included young investigator-initiated COBRE
projects, COBRE pilot projects, and other NIH research applications, both within and outside of MaineHealth
Institute for Research. A significant Phase I accomplishment was the award of an NIH S10 shared instrument
grant in support of a new high resolution TripleToF mass spectrometer, liquid chromatograph, and other
support equipment. MaineHealth provided institutional funds to renovate the facility, which consolidated the
current and new equipment in a more efficient footprint. This support has increased our capacity, efficiency,
and flexibility by allowing expanded proteomics and lipidomics workflows and increased user access, while
providing new opportunities to support ongoing research and training for internal and external users. In phase
I, we recruited an outstanding mass spectrometry technology manager, Carlos Gartner PhD, who brought
expertise that includes mass spectrometry instrumentation and advanced liquid chromatography. We also
recruited Yulica Santos-Ortega, PhD as a research associate with mass spectrometry-based cardiovascular
proteomics experience. New Phase II opportunities include exploitation of human proteome-wide selected
reaction monitoring protocols using on-line data repositories that will be implemented on new instrumentation
(Sciex QTRAP 6500+). We continue to be uniquely positioned as the only regional facility of its kind providing
these services for scientific inquiry and in support of student, investigator, and staff training. Within this
COBRE, these resources will be critical for promoting junior investigator advancement. This core will advance
our understanding of the properties of thermogenic adipocyte lineages and roles in energy balance (Project 1,
M. Lynes), provide insight into the role of the X/A cell secretome on bariatric surgery-related bone loss (Project
2, Z. Li). This core will also be well positioned to support PI progress and future exploratory directions for
identification of modifiable risk factors in cardiometabolic disease (Project 3, I. Agarwal).